An early life multivalent immunization strategy for induction of neutralization breadth

ABSTRACT
In 2023, adolescents and young people accounted for approximately 25% of new HIV infections globally. The
period after weaning but before sexual debut represents a window of relatively low HIV acquisition risk,
providing an opportune time for administering a multi-dose vaccine regimen to elicit protective immunity prior to
adolescence. The success of a protective HIV vaccine will rely on the induction of broadly neutralizing
antibodies (bnAbs). Given the potential for rapid bnAb development in children living with HIV, vaccines
targeting B cell evolution towards bnAbs may be more effective in early life. Germline-targeting immunization
strategies have shown great potential by using a series of priming, shaping, and polishing immunogens to
activate bnAb precursor B cells and guide them towards potent and broad neutralization. While these priming
immunogens effectively engage bnAb precursors, identifying appropriate strategies to drive bnAb evolution
remains a challenge. The overall goal of this project is to identify an optimal prime-boost strategy to guide
antibody maturation towards neutralization breadth in the setting of immune maturation. We hypothesize that
an early life HIV immunization strategy incorporating multivalent HIV env immunogens will drive efficient
priming and maturation of B cell responses towards neutralization breadth. Our hypothesis will be investigated
under the following aims: 1) Compare sequential versus simultaneous administration of germ-line targeting
immunogens for induction of CD4bs and V2 apex bnAb precursors; 2) Determine whether a multivalent prime-
boost strategy will better drive the development and maturation of bnAb lineages towards neutralization
breadth.; and 3) Define the evolution of vaccine-elicited B cell responses and mAbs following immunization
with bnAb B cell lineage designed immunogens through a structure-to-sequence approach. The proposed
studies will help establish a prime-boost regimen to evolve bnAb B cell lineages throughout early childhood
towards neutralization breadth prior to adolescence. These studies will establish early life as an optimal time
for beginning a sequential HIV immunization strategy and inform the next phase of bnAb germline-targeting
immunization strategies for evaluation in preclinical and human clinical trials.

Public health relevance
PROJECT NARRATIVE The key to a successful HIV vaccine will rely on its ability to induce neutralizing antibodies that can protect against a variety of circulating strains. We are exploring a variety of vaccination strategies to induce these broadly protective neutralizing antibodies (bnAbs), such as using HIV envelope constructs designed to induce two distinct bnAb lineages administered via nanoparticle technology as well as the ability of multivalent boosting immunogens to diversify the antibody repertoire. The goal is to create an early-life vaccine strategy that will induce cross-protective antibodies, thereby establishing life-long immunity prior to adolescence.